FUNCTIONAL IMAGING OF VENTROMEDIAL HYPOTHALMUS IN NORMAL, DIABETIC,AND OBESE PTS

This study is to determine the effect of hyperinsulinemia and hypoglycemia on ventromedial hypothalamic (VMH) metabolism in normal, diabetic and obese subjects using functional magnetic resonance imaging techniques.